Pharmacological Sciences Training Grant

This application requests 5-years of financial support for training in the pharmacological sciences
for six outstanding predoctoral fellows at Saint Louis University. The leadership team includes
three experienced research educators who will guide the efforts of 30 well-funded preceptors from
eight departments in the Colleges of Medicine, Arts & Sciences, and Biomedical Engineering. Our
training program is based on the premise that pharmacology is a broadly-based subject requiring
a multidisciplinary and integrative approach. We have two goals. The first and most immediate
goal is to ensure competency in modern principles of drug action and related disciplines. Our
second and long-term goal is to develop a diverse pool of capable scientists trained to address
the challenges presented by barriers to successful treatment of human disease. To achieve these
objectives, we designed a training program that includes didactic and interactive instruction in the
principles of drug action, grant construction, responsible conduct of research, and methods to
enhance reproducibility; seminar and journal club series specifically targeted to drug discovery
and medicinal chemistry; career development seminars that include presentations by scientists
pursuing alternative career paths; instruction in presentation and teaching skills including an
active role as teacher in an undergraduate course completely administered and taught by
pharmacology graduate students; and, competitive student presentations at a yearly retreat. Past
graduates of our training program now pursue successful careers in research, academics, and
industry, including several trainees who hold significant leadership positions in universities and
businesses.

Public health relevance
This is a new application that builds upon a 30-year history of federal funding for predoctoral training in the pharmacological sciences at Saint Louis University. Our broadly-based multidisciplinary approach involves 30 faculty from eight departments in the Colleges of Medicine, Arts & Sciences, and Engineering at Saint Louis University. The training program includes classical concepts of pharmacokinetics, pharmacodynamics, and toxicology, as well as state-of- the-art quantitative biology, chemical biology, and drug discovery technology and approaches.